METAL LIGANDS AND GEOMETRY OF THE METAL-BINDING SITE IN THE TRANSMEMBRANE DOMAIN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. XAS will be used to determine the local site structure of the metal in the transport domain of the heavy-metal transporter ZntA.